Histology, Tissue Processing and High Content Microscopy

ABSTRACT
Histology, Tissue Processing and High Content Microscopy Core
The Histology, Tissue Processing and High Content Microscopy Core will continue to serve the needs of
UCSD vision researchers by providing dedicated tissue processing equipment and a part-time
histotechnician experienced in eye histology and immunohistochemistry. The Histology, Tissue Processing
and High Content Microscopy Core supports both paraffin and cryosection processing and various staining
strategies. The core also provides vision researchers with 1) advice for fixation selection depending on
study purpose; 2) paraffin and cryo blocking of study samples; 3) paraffin or cryo histology slide preparation
with customized staining, 4) assistance for proper interpretation and precision microsampling of the region
of interest for electron microscopy evaluation and 5) high content confocal imaging for drug screening and
histologic specimen imaging.